Cancer Center Support Grant

Project Summary
Institutional efforts are required to achieve the level of diversity, equity, and inclusion that will ensure
recruitment and advancement of individuals now underrepresented in academic medicine (URiM). Siteman
Cancer Center (SCC) is committed to overcoming structural barriers that have limited diversity in the cancer
research workforce and to supporting the success of early career cancer researchers. Aligned with the NCI
National Cancer Plan Goals to eliminate inequities and to optimize the workforce, and with the support of a
CCSG Supplement, SCC has implemented a Training Navigation program. The overarching goal of this
program is to provide personalized navigation to resources and services that enhance the career development
and trajectory of early career scholars (particularly postdoctoral fellows and early-stage investigator faculty),
including women and those from backgrounds that are URiM. This SCC effort is a collaboration between
Cancer Research Training and Education Coordination (CRTEC) and Plan to Enhance Diversity (PED).
Importantly, CRTEC and PED staff collaborate to ensure that early career scholars benefit from navigation
support and programming, and that all SCC scholars receive exceptional support during graduate school,
postdoctoral work, and as ESI faculty. We previously trained a PED staff member as a training resource
navigator to provide hands-on support and link scholars to career development resources and programs. To
support scholars, particularly URiM and women, we will continue to evaluate, improve, and sustain our training
navigation infrastructure and programs in order to promote resource access and build a climate conducive to
persistence and success in cancer research careers. Our aims are to: (1) Identity competitive and promising
underrepresented cancer-focused trainees and ESI faculty within SCC and the region; (2) Provide
personalized navigation to resources, professional preparation, and networking opportunities; and (3) Evaluate
program outcomes and evolve the program as needed to meet changing needs and opportunities, while
implementing plans for sustainability of our high-impact activities. Our objective is to conduct activities that
improve the training climate and increase participation of URiM and women scholars in training and career
development programming. Navigation is a key strategy for linking scholars to the supports they need and
want, and we have planned a sustainable approach. Specific initiatives include proactive and personalized
navigation, grant writing and biosketch training, access to scientific editing and grant reviews, support for travel
to cancer conferences, and other professional development opportunities. Short-term outcomes include equity
and inclusion in scholars reached and supported, scholars linked with NCI program officials, participation in
training activities, and grant submissions including career development awards and diversity supplements.
Longer-term outcomes include grants awarded, and equitable retention in cancer research and career
progression. Our approach is designed for long-term success in building a diverse cancer research workforce.

Public health relevance
Project Narrative Siteman Cancer Center (SCC) is committed to overcoming structural barriers that have limited diversity and equity in academic medicine and the cancer research workforce. The overarching goal of the SCC initiative to Strengthen Research, Training, and Outreach Capacity is to provide personalized training navigation to link scholars to cancer research supports. SCC staff will collaborate to implement infrastructure and processes that increase: trainee awareness and use of shared cores and resources appropriate to their interests; identification of mentors; awareness of catchment priorities and cancer health inequities; and trainings including grant writing, scientific editing, and travel supports to advance the career development and trajectory of SCC trainees.